Development of an ultra-sensitive, laser-based, carbon-14 spectrometer for molecular speciation of liquid-chromatography analytes and small, biological samples

The feasibility of laser-­based, detection of carbon-­14 at Accelerator Mass Spectrometer (AMS) sensitivities has been demonstrated, but these instruments require large samples sizes and lack compatibility with systems common to biological labs?such as liquid chromatography-­mass spectrometry (LC-­MS). With their ability to quickly detect and quantify ever smaller amounts of material, LC-­MS systems are valued for their capacity to isolate individual biomolecules. As a result, LC-­MS coupling is now stipulated for the success and adoption of new biological instrumentation. Consequently, we propose to develop a laser-­based, carbon-­14 spectrometer for biology using saturated-­absorption cavity ring-­down spectroscopy (SCARS). This instrument will have similar sensitivity to AMS (~10-­15 14C/C limit-­of-­detection), the ability to handle nanogram to microgram sized samples, and the capability to measure analytes separated by LC systems. This level of carbon-­14 sensitivity and the techniques it affords are currently restricted to room-­sized AMS instruments that cost millions of dollars and require several dedicated Ph.D. level scientists for operation. The SCAR instrument would be much smaller (table-­top sized), cheaper, and easier to operate. The accessibility coupled with the extreme sensitivity of this technology will enable high-­throughput, small-­sample-­size experiments and bring carbon-­14 measurements into the modern biological laboratory. This instrument will enhance LC/MS systems?providing a means to quantitatively analyze complex biochemical systems in any research lab. This will have an impact on biology from basic science experiments to more applied human subject studies in drug development.

Public health relevance
Using the radioisotope carbon- 14 to label organic molecules in biological systems allows scientists to trace small doses of nutrients, toxins, and therapeutics in humans and animals, but detecting these small carbon- 14 quantities for these experiments has traditionally required complex, expensive, room- sized instruments. If funded, this project will develop a table- top sized instrument that would make these techniques available to any biomedical lab in the world, and the instrument could be coupled to modern analytical tools such as liquid chromatography and mass spectrometry. This will enable new regimes of experimentation;; offering a more precise tool for tracking target species through complex biochemical systems, allowing for better animal studies, and providing a path to transition from costly and often unrepresentative animal models to phase- 0 micro- dosing human trials for the development of new pharmaceuticals.